SLEEP AND IMMUNE MECHANISMS IN RHEUMATOID ARTHRITIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. SPECIFIC AIMS The specific aims of this study are as following: Aim #1: To determine the nature and severity of disordered sleep RA patients vs. controls. A comprehensive assessment of sleep will be completed including polysomnographic recordings and power spectral analyses during baseline sleep and following partial night sleep deprivation (PSD) in RA patients vs. age-, gender- and ethnicity matched controls. Aim #2: To evaluate the effects of sleep and sleep loss on pain, fatigue, and mood, and on sympathovagal balance and proinflammatory cytokine activity in RA patients and controls. a) To examine the relationship between sleep, inflammatory cytokines and behavioral measures during and following a night of baseline sleep. Behavioral symptoms of pain, fatigue and mood will be profiled upon waking, during the day and prior to sleep in RA patients and matched controls. Diurnal and nocturnal proinflammatory cytokine activity (i.e., circulating levels, intracytoplasmic production, and RT-PCR of cytokine gene products) will be repeatedly examined along with non-invasive assessment of sympathovagal balance (i.e., power spectral density analysis of HRV) across baseline b) To evaluate the effects of a single night of partial sleep deprivation on inflammatory cytokines, sympathovagal balance and behavioral measures. Aim #3: To examine the contribution of nocturnal proinflammatory cytokines on sleep and other behavioral symptoms in RA patients. Prior to sleep onset, proinflammatory cytokine activity will be determined along with assessment of EEG sleep in RA patients vs. controls.